Novel Aglains as Therapeutic Agents for Mosquito-borne Arboviruses

PROJECT SUMMARY/ABSTRACT
Novel Aglains as Therapeutic Agents for Mosquito-borne Arboviruses
This proposed R01 research program seeks to develop novel aglain derivatives as host-targeted
antivirals against dengue virus (DENV) and other mosquito-borne arboviruses. DENV ranks among the World
Health Organization’s top ten threats to public health worldwide and is listed as an NIH Category A Priority
Pathogen. Current treatment options for DENV are limited and include an approved vaccine with modest
efficacy. Moreover, there is a severe lack of approved DENV antiviral agents and an urgent need for
therapeutics that can reduce morbidities and lower infection burden. We have identified aglains such as
CMLD013854 with potent activity against DENV-2 which extends to all other DENV serotypes. In early
structure-activity relationship (SAR) studies, we have begun to map the structural requirements necessary for
efficacious antiviral activity, including enantiospecificity. Target identification experiments, including the
Proteome Integral Stability Alteration (PISA) assay, have identified the host target vesicle amine transport 1
(VAT-1), a member of the NADPH-dependent quinone oxidoreductase family, as the host target modulating
antiviral aglain action. Here, we seek to optimize the aglain chemical series as a new class of host-targeted
antivirals. Further, we will use CMLD013854 and other antiviral aglains as tool compounds to study their
modulation of VAT-1 and define the antiviral consequences of VAT-1 inhibition to DENV infections. Our
medicinal chemistry program will map antiviral aglain SAR by systematically varying four regions of the aglain
core and use this SAR to guide optimization of potency, selectivity, and pharmacological properties. Our lead
optimization efforts will focus primarily on DENV, but will also extend to other mosquito-borne viruses including
CHIKV and ZIKV, both listed as NIH Category B Priority Pathogens. To guide the project, we will deploy
focused advancement criteria to ensure prioritization of leads with optimal activity and pharmacological
profiles. Other key objectives of this project include biochemical assays to interrogate CMLD013854’s mode-
of-action targeting VAT-1, X-ray crystallography of VAT-1/aglain co-complexes, studies to define the role of
VAT-1 in DENV-2 infection, and execution of pharmacokinetic, safety, and in vivo antiviral efficacy studies for
top aglains, including murine infection models for both DENV and ZIKV. This multidisciplinary collaboration will
be jointly led by PIs with complementary expertise in organic synthesis/target identification (Porco) and virology
(Chu) and is enhanced by co-Investigators with expertise in medicinal chemistry (Brown) and structural
biology/biochemistry (Allen). Successful execution of this project will advance a novel class of antivirals and
build a comprehensive understanding of their unique mode-of-action.

Public health relevance
PROJECT NARRATIVE Novel Aglains as Therapeutic Agents for Mosquito-borne Arboviruses Dengue virus (DENV) ranks among the World Heath Organization’s top ten threats to global health worldwide and is listed as an NIH Category A priority viral pathogen. We have identified synthetic aglain derivatives with potent, selective activity against all dengue virus serotypes and broad-spectrum anti-arbovirus activity extending to related flaviviruses such as Zika virus (ZIKV) and alphaviruses such as chikungunya virus (CHIKV) via modulation of the host target vesicle amine transport 1 (VAT-1). This project seeks to pharmacologically optimize our lead aglain series against multiple arboviruses and fully elucidate their VAT-1 targeting mechanism in order to advance preclinical development of this new class of host-targeted antivirals with a novel antiviral target.